Real-Time Articulation-to-Speech Mapping for Enhancing Impaired Oral Communication

? DESCRIPTION (provided by applicant): The goal of this project is to test the efficacy of a silent speech interface (SSI) as an alternative mode of oral communication for persons who are unable to use their voice (e.g., after laryngectomy, surgical removal of larynx due to the treatment of cancer). We have recently developed a real-time, interactive SSI based on a commercial electromagnetic articulograph. The SSI converts tongue and lip movement to text, and then plays back corresponding synthesized speech sounds with natural sounding voice in real-time. The SSI has potential to restore the patient's voice by identifying the patient's voice characteristics before laryngectomy. Preliminary tests on healthy participants demonstrated the feasibility of the SSI. In this project, we further evaluate the system by studying 15 participants after laryngectomy and 15 age- and gender-matched healthy controls. If successful, the SSI has the potential to transform clinical practice for speech-language pathologists other related health care professionals. The proposed research will enhance human health by making an impact on individuals after laryngectomy and potentially to a broad range of other speech and voice disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Silent speech interfaces (SSIs) are a novel alternative mode of oral communication for persons who are unable to produce speech sounds (e.g., individuals who undergo a laryngectomy, removal of larynx due to the treatment of laryngeal cancer). SSIs recognize speech sounds from articulatory data and then drive text-to-speech synthesis, which produces speech with natural sounding voice, which is one of the advantages over the current treatment options for these individuals. SSIs hold potential to even restore the patient's own voice by identifying the patient's voice characteristics before laryngectomy. Although participants after laryngectomy will be the test case in this project, the clinical implications of SSIs extend to a larger population of persons with other speech and voice disorders.